Zebrafish International Resource Center

PROJECT SUMMARY
Zebrafish is a premiere organism to study vertebrate development, physiology, behavior, genetics, and
disease. Powerful techniques allow efficient generation and recovery of zebrafish mutations affecting genes
that regulate developmental patterning, organogenesis, physiology and behavior. Recent advances make it
easy to study gene function in transgenic zebrafish and with antisense oligonucleotides. The functions of
many, if not most of these genes are conserved among vertebrate groups. Thus, analysis of zebrafish
mutations provides insights into gene function in other vertebrates, including humans.
The Zebrafish International Resource Center (ZIRC) has been established as a repository that provides
genetically modified animals, materials, and services to the research community. The parent grant provides
funding 1) to serve as a central repository for zebrafish genetic stocks and research materials, 2) to provide
pathology services and consultations, and 3) to develop a platform, based on a panel of PCR assays, to
screen for the most prevalent pathogens of laboratory zebrafish. These materials, services, and information will
be made widely available to the research community.
Since its inception, ZIRC expends considerable time and resources on the facility's biosecurity when importing
fish. We also maintain an extensive system to monitor the health of our stocks to limit the spread of two of the
most common pathogens, Pseudoloma neurophilia and Mycobacterium chelonae. The requested supplemental
funds will be used to alter and renovate the facility so that we can eliminate P. neurophilia infections in our
wild-type stocks. We will alter the food preparation room and parts of the main fish facility, and we will
purchase water filtration, fish housing, food room, and PCR diagnostic equipment. The equipment and space
alterations will support screening for, rearing, and ultimately maintaining stocks that are free of P. neurophilia
and have significantly lower prevalence of M. chelonae.

Public health relevance
NARRATIVE The Zebrafish International Resource Center 1) provides a central repository for zebrafish genetic stocks and research materials, 2) provides consultation and pathology services, and 3) develops a pathogen screening platform. These materials, services and information are made widely available to the research community.